The Missing Millions: Identification and infectiousness of undiagnosed tuberculosis cases in the community (the MI-TB study)

PROJECT SUMMARY/ABSTRACT
A startling 40% of tuberculosis (TB) cases in endemic countries are “missing” (~4.2 million cases globally remain
undiagnosed or unreported)! Undiagnosed cases may substantially contribute to disease transmission as ~30% are
smear positive while having an asymptomatic or minimally symptomatic presentation. These undiagnosed cases
serve as a reservoir in the community and severely undermine TB control efforts.
In the recently completed NIH-funded CASS I study we performed cough aerosol sampling on 453 patients with
newly diagnosed TB (detected by passive case finding) and found ~30% were highly infectious – containing
culturable M. tuberculosis bacilli in their respirable cough aerosols (<10uM infectious inhalable particles that initiate
disease). Multivariate analysis revealed relatively healthier, HIV negative patients who were not on TB treatment
and had a high bacillary load were more likely to be highly infectious. We have also developed a novel low-cost
mobile mini-clinic housing a novel TB diagnostic and HIV/CD4 testing capabilities. Using this mobile mini-clinic we
have screened 4700 individuals in the communities of Cape Town and found 475 cases of suspected TB, 54 of which
had confirmed TB. By combining these two techniques we found an unsettling ~17% of undiagnosed TB cases are
highly infectious.
Sizable gaps exist in our knowledge of community-based TB patient infectiousness and transmission. We do not
know the ‘bioprofile’ of infectious undiagnosed cases in the community nor their degree of infectiousness, and a
chasm remains in our understanding of patient level infectiousness and TB transmission. These have implications for
targeting contact tracing investigations and the development of a scalable screening tool to measure infectiousness.
In the proposed study we will employ active case finding using a novel mobile-mini clinic to detect ‘missing’ TB cases
and establish their degree of infectiousness using cough aerosol sampling (Aim 1), determine a biosignature and
bioprofile of infectious but minimally symptomatic undiagnosed individuals (Aim 2), and accurately model the
impact of active case finding on disease transmission using estimates generated in the study, thus informing policy.
In summary, this project will elucidate the bioprofile of undiagnosed minimally symptomatic active TB cases in the
community – ‘the missing millions’, and further our understanding of the fundamental biology of TB transmission,
potentially uncovering targets to interrupt disease spread.

Public health relevance
PROJECT NARRATIVE The infectiousness and pathobiology of tuberculosis (TB) transmission from community-based undiagnosed active TB cases remains unexplained. In this project, we will undertake active case finding in a high burden setting to quantify and phenotype asymptomatic or minimally symptomatic infectious TB cases in the community using novel cough aerosol sampling, RNA sequencing and FDG-PET-CT imaging. Understanding the phenotype of undiagnosed infectious TB cases will enhance our ability to rationally design TB transmission interventions thus impacting disease burden.